Imaging Core

PROJECT ABSTRACT
As a part of the USC Alzheimer Disease Research Center competitive renewal, the Imaging Core will
continue to serve the overall mission to provide high-quality MR and PET imaging resources to the
local and broader AD research community. The ADRC Imaging Core will provide core resources, including
MR physics and PET expertise, multi-scanner sequence and protocol development, image data quality control
and management, research collaboration, and a global framework for conducting AD neuroimaging research.
The Imaging Core is led by a well-integrated and collaborative team, including Arthur Toga (Core Leader),
Judy Pa (Core Co-Leader), Meredith Braskie, Danny JJ Wang, Nasim Sheikh-Bahaei, and Paul
Thompson, who together provide expertise in vascular, functional, and structural imaging and its analyses for
3T and 7T MRI, and PET. We propose 5 specific aims that provide an imaging framework for all ADRC
projects; perform high quality control of all imaging data; develop technical and scientific approaches for ultra-
high field 7T MRI; assist in PET protocol development and quality control; and conduct education and training
in modern imaging techniques. Taken together, these goals will serve the USC ADRC’s unifying scientific
theme of vascular contributions to Alzheimer disease: risk factors, neurovascular and metabolic mechanisms,
and risk reduction.